Training in Clinical and Epidemiological Research for Liberia (TRACER)

Project Summary/Abstract
Liberia has a high burden of infectious diseases and has suffered from both the short-term (e.g.,
Ebola, Lassa Fever, malaria, and tuberculosis) and long-term (e.g., post-acute sequelae of Ebola,
Lassa Fever-related deafness, and HPV-related cervical cancer) manifestations of these infections.
A protracted civil war left the country vulnerable to the Ebola epidemic, which further contributed to
the collapse of Liberia’s educational institutions. As a result, there are very few highly-trained local
investigators who can lead epidemiologic and clinical research in Liberia in order to respond to
current and future infectious disease threats. To respond to this need, our program, “Training in
Clinical and Epidemiologic Research for Liberia” (TRACER), coalesces a collaboration between
Univ. of California, San Francisco (UCSF), University of Liberia College of Health Science (ULCHS),
and Univ. of North Carolina (UNC), in partnership with PREVAIL (an intramural NIAID research
platform). This renewal application builds on our first cycle, in which we a) identified three Liberian
trainees and supported their completion of a rigorous Master’s Degree in Clinical and Epidemiologic
Research at UCSF; b) buoyed two of the trainees into admission to the UCSF PhD Program in
Epidemiology and helped the third to be selected as the new Director of PREVAIL; and c) worked to
achieve approval from ULCHS to begin Liberia’s first PhD Program in Epidemiology. The
overarching goal of our next cycle is to strengthen the ULCHS Epidemiology PhD program to enable
it to produce world-class scientists who both perform research and teach others. Our objectives are:
1. Complete provision of foundational education and mentoring in applied research leading
to a Ph.D. Degree in Epidemiology and Translational Research at UCSF to two Liberian
scholars who began their training during the first cycle of our training program;
2. Assist in the development and maturation of the PhD program in Epidemiology at ULCHS,
which is envisioned to be the primary future vehicle for obtaining the training needed in
Liberia for independence and excellence in human participant-based research; and
3. Support 4 Liberian trainees who will enroll in the new ULCHS Epidemiology PhD Program.
A two-year fundamental curriculum in epidemiology and biostatistics will underlie the PhD Program
and be made available to other ULCHS students. Our current TRACER trainees will contribute to
the core teaching faculty. Research platforms directed by mentors at UCSF, UNC and PREVAIL will
provide numerous mentored research opportunities for trainees. By the end of the funding cycle, it
is expected that Liberia will make substantial strides in training world-class epidemiologic and clinical
researchers able to address the infectious disease-related conditions most relevant to Liberia.

Public health relevance
Project Narrative This renewal application of our ‘Training in Clinical and Epidemiologic Research for Liberia’ (TRACER) program proposes to extend the success we achieved in our initial funding cycle in which we a) identified three Liberian trainees and supported their completion of a rigorous Master’s Degree in Clinical and Epidemiologic Research at University of California, San Francisco (UCSF); b) buoyed two of the trainees into admission to the UCSF PhD Program in Epidemiology and helped the third to be selected as the new Liberian Network Director of PREVAIL, a major NIH-funded research organization in Liberia; and c) worked to achieve approval from University of Liberia (UL) to begin the country’s first PhD Program in Epidemiology. The goal of this proposed next cycle is to strengthen the UL PhD Program in order to achieve its goals of producing world-class investigators in Liberia and promoting locally-led research. We will achieve this by a) supporting the completion of UCSF PhD training by two of our first-cycle TRACER scholars in order to propel them to become core faculty members at UL; b) further developing the curriculum of the UL PhD Program; and c) and supporting the enrollment of four trainees into the UL PhD Program.